Inserting carbide in ligand templated iron-sulfur clusters and their reactivity towards hydrides and N2

PROJECT SUMMARY
Nitrogenases provide nearly all bioavailable nitrogen by catalytically reducing N2 to produce NH3. The active
site for N2 reduction is an iron-molybdenum cofactor (MoFe7S9C, or FeMoco) that features high-spin iron centers
bridged by sulfide (S2−) and an intriguing carbide (C4−) that bridges six iron centers. This biologically
unprecedented carbide ligand raises questions concerning its mechanism of insertion into FeMoco. The carbide
originates from a methyl group transferred to an iron-sulfur cluster by a S-adenosylmethionine (SAM) enzyme.
However, the mechanisms that convert this methyl group into the final interstitial carbide, and the intermediates
along the way, remain unknown. The fact that natural systems insert this carbide into nitrogenases also leads to
questions about the structural and electronic impact of carbide on the reactivity of FeMoco.
A primary aim of this proposal is to study carbide insertion in iron-sulfur clusters to understand what
chemically feasible intermediates may be relevant to the biosynthesis of FeMoco. While studying the
biosynthesis of FeMoco is difficult in the native enzyme, model clusters provide us synthetic control over specific
structural and electronic factors to systematically test our hypotheses. Our main strategy is to design and
synthesize scaffold ligands that can template trinuclear iron clusters featuring only sulfur donors. The sulfur
donors will yield high-spin, coordinately unsaturated iron sites that mimic iron's coordination environment in
FeMoco. We propose to install methyl (CH3), carbene (CH2), carbyne (CH), and carbide (C) ligands in the iron-
sulfur clusters and study the interconversion between these compounds. These species are proposed
intermediates during the biosynthesis of FeMoco, and the interconversion between these clusters will inform us
what chemical transformations are feasible during the biosynthesis of FeMoco.
Finally, we aim to explore N2 binding by iron-sulfur clusters. We propose that these are best accessed from
hydride-bridged iron-sulfur clusters, in a biomimetic mechanism that will help to elucidate the ability of H2
elimination for enabling N2 binding. We will install hydride ligands on these biomimetic clusters and exploit
reductive elimination of H2 to enable N2 binding. This process mimics the E4 intermediate during N2 reduction by
FeMoco. These studies will advance our fundamental understanding of key intermediates and mechanisms
during N2 reduction in FeMoco.
My training in the Holland group will expand my technical research aptitudes, mentorship, and critical writing
and presentation skills. Yale's collection of leading bioinorganic and synthetic inorganic chemists renders it an
ideal setting for gaining skills in bioinorganic chemistry, ligand design and synthesis, and mechanistic studies.

Public health relevance
PROJECT NARRATIVE Nitrogenase enzymes possess an iron-molybdenum cofactor (FeMoco) that catalyzes the conversion of nitrogen to ammonia, yet key steps regarding the biosynthesis of FeMoco and its mechanism of N2 binding remain unknown. To mimic the biosynthesis of FeMoco and examine its mechanism of N2 binding and reduction, we propose to design ligand templated iron-sulfur clusters and study the incorporation of carbide and hydride ligands in these model systems. The reactivity of our proposed high-spin, carbide and hydride bridged iron-sulfur clusters will yield valuable insight into the biosynthesis and catalytic activity of FeMoco.